Protein Structure/Molecular Basis Of Schindler/Fabry

The degradation of cellular molecules is a normal process that can go awry. Defects in the degradation of various cell macromolecules cause disease and are usually the result of mutations in specific enzymes. Two key enzymes in the degradation of cellular carbohydrates are alpha-N-acetylgalactosaminidase and alpha-galactosidase. Mutations in these enzymes cause Shindler and Fabry diseases, respectively. We have determined the structure of alpha-N-acetylgalactosaminidase and alpha-galactosidase by x-ray diffraction techniques. We have mapped the locations of mutations that give rise to Shindler and Fabry diseases and have begun to describe the catalytic mechanisms by which the enzymes perform their normal function of carbohydrate degradation.